Afferent proprioceptive signaling in Drosophila larvae

ABSTRACT
Proprioception is the sense that allows animals to monitor their body position and movements; proprioceptive
deﬁcits lead to severe challenges in moving and maintaining posture. Proprioceptive feedback passes from
sensory neurons through two central nervous system (CNS) pathways: local pathways targeting motor
circuits, where proprioception adjusts ongoing movements, and projection pathways to the brain, where
proprioception is used to learn and plan future actions. The fundamental diﬀerences between projection
and local pathways remain largely unknown. Our long-term goal is to understand proprioceptive circuit
activity during natural animal behavior, emphasizing the roles played by genetically-deﬁned cell types, which
will facilitate the discovery of stem-cell-based therapies for injury and proprioceptive dysfunction.
This proposal's objective is to characterize fundamental diﬀerences between projection and local
pathways. We focus on second-order neurons, CNS neurons that receive direct input from proprioceptive
sensory neurons of each pathway. We will speciﬁcally address the following questions: does the brain receive
minimally processed stimulus information or integrated representations of speciﬁc stimulus features? Is
information presented to the brain in a behavioral state-dependent manner? Does the brain receive privileged
types of information in comparison to local circuitry?
We use Drosophila larva as a highly tractable model to study proprioception. This proposal deploys
two major technical innovations: CRASH2p microscopy, which allows for volumetric imaging of neural
dynamics in intact, freely moving, and behaving larvae, and connectomics, which allows for comprehensive
reconstruction of synaptic connections between second-order neurons and their synaptic partners. Based on
preliminary data, we will test the central hypothesis that local and projection second-order proprioceptive
neurons diﬀerentially integrate and process naturally occurring self-movement stimuli. We test this hypothesis
using complementary in-depth (functional, Aim 1) and in-breadth (anatomical, Aim 2) experimental strategies.
The proposed research is signiﬁcant because it will provide two advances that remain, to date, out of
reach in other models. First, it will provide a comprehensive anatomical understanding of the diversity of
second-order proprioceptive neurons and the networks in which they are embedded. Second, it will produce
ﬁrst-of-its-kind knowledge of the activity of second-order proprioceptive neurons in intact animals performing
multiple behaviors and determine the role of a speciﬁc type of proprioceptor in shaping that activity. Thus, our
work is expected to provide a new conceptual framework for how diverse second-order neurons integrate
and process proprioceptive information and how the brain senses proprioceptive stimuli.

Public health relevance
PROJECT NARRATIVE The proposed research addresses critical knowledge gaps recently identified by the NIH, the characterization of functional circuits between central and peripheral nervous systems in physiological conditions, and the need for effective technologies and approaches to measure and modulate interoceptive processes. The first outcome of the proposed research is expected to be an anatomical framework for how second-order proprioceptive neurons in the CNS transmit physiological self-movement stimuli from proprioceptors to motor circuits and the brain. The second outcome of the proposed research will be to develop and use a new two-photon- based tracking microscope for recording and manipulating neuronal activity in intact, freely moving animals during multiple behaviors.